Shark Radiotherapy for the Treatment of Triple-Negative Breast Cancer

SUMMARY
Triple-negative breast cancer (TNBC), which lacks expression of the estrogen receptor, progesterone
receptor, and HER2, is the most aggressive breast cancer subtype with a five-year survival rate of 12% for
patients with metastatic disease. Since traditional hormonal therapies are ineffective, few therapeutic options
exist for TNBC. Radiopharmaceutical therapies (RPTs) have demonstrated improved survival for several types
of cancer, however, there is dearth of RPTs for TNBC. Our goal is to improve outcomes for TNBC patients by
developing first-in-class targeted RPTs. One attractive target for the development of RPTs is the receptor
tyrosine kinase c-MET. c-MET is overexpressed in nearly two-thirds of all TNBC cases and c-MET signaling
results in disease with an aggressive phenotype. Studies have also shown that radiation induces c-MET
overexpression suggesting that targeting c-MET with RPTs may result in a feed-forward mechanism where the
cancer cells become lethally addicted to RPT. To develop a targeted RPT, we identified a novel Variable New
Antigen Receptor (VNAR) binding domain from a nurse shark immunized with the extracellular domain of c-MET.
VNARs are the antigen recognition domains of shark antibodies, and at ~11kDa they are the smallest naturally
occurring variable fragment. Consisting of a single-chain, VNARs have two complementarity determining regions
and two additional variable regions that allow them to adopt multiple unique conformations. Because of their
usual geometries, VNARs can engage cryptic epitopes inaccessible to conventional human and camelid
antibodies with high affinity. Surprisingly, VNARs also have low to no immunogenicity making them readily
translatable. The VNAR we discovered, 2H4, was made into a human Fc fusion protein (2H4-Fc) to increase
valency and prolong the in vivo half-life. 2H4-Fc was cross-reactive with c-MET across multiple species,
specifically bound c-MET-positive cells lines by flow cytometry and was internalized on receptor binding. In a
PET imaging study, [89Zr[Zr-2H4-Fc localized to a TNBC xenograft resulting in high tumor uptake with an
exceptionally low background in non-target tissues. The objective of this proposal is to evaluate the ability of
our novel targeting vector 2H4-Fc to deliver α- and β-emitting radionuclides (225Ac and 177Lu) for therapeutic
benefit in vivo. The first specific aim is to determine the dosimetry of our RPTs and evaluate normal tissue
toxicity. In the second aim, we will evaluate their therapeutic efficacy in vivo using multiple TNBC models and
investigate the biological effect and mechanism of action of our RPTs. In the third aim, we will conduct studies
in non-human primates to determine the immunogenicity of 2H4-Fc in addition to its pharmacokinetic and
pharmacodynamic properties by PET imaging. This innovative proposal aims to provide compelling evidence for
the further development of c-MET-targeted RPTs for use in TNBC.

Public health relevance
NARRATIVE Triple-negative breast cancer (TNBC) is a highly lethal subtype of breast cancer and there is an unmet need to develop innovative, effective therapies to combat TNBC. Radiopharmaceutical therapies (RPTs) are in development for nearly all forms of cancer, however, no FDA-approved RPTs exist for TNBC nor are there any undergoing clinical trials. The goal of this project is to develop a clinically relevant therapeutic strategy using targeted RPTs derived from sharks that will effectively and safely deliver therapeutic radionuclides to the tumor resulting in an increased therapeutic index for RPTs and improved patient outcomes.